Mid-Career Program for Vascular Contributions to Alzheimer's disease

The goal of this K24 revised application is to build and enhance a research and training program focusing on
investigating mechanisms and potentially related therapies for vascular contributors to cognitive aging and
Alzheimer’s disease (AD). The scientific basis for focusing on this area of Patient-Oriented Research (POR) is
that increasingly, alterations in both systemic and brain vascular systems are being identified as risk factors and
potentially involved in the causal pathway for both age-related cognitive decline and dementia, including AD.
Cardiovascular disease (CVD) and Alzheimer’s disease (AD) share many risk factors, such as hypertension and
diabetes. A common potentially unifying hypothesis is that both CVD and AD involve an endothelial dysfunctional
state that affects multiple brain processes such as perfusion, hemodynamic regulation, blood-brain barrier
permeability, atherosclerotic progression and immune-inflammatory pathways leading to cognitive decline and
AD pathology. From a therapeutic perspective, angiotensin receptor blockers (ARB) have a pleiotropic effect on
the endothelium and my studies conducted over the last few years suggest it has a therapeutic potential. My
career aims under this application is to (a) establish a POR training program focused on clinical trials into my
current and future funded research activities; (b) Identify and train clinician and non-clinician investigators,
particularly from underrepresented minorities, interested in being engaged in POR; and (c) enhance my research
skills- through learning new proteomic methods and cell biology for development of biomarkers in AD clinical
trials, and mentorship skills in POR. To achieve these career goals, I will leverage an excellent research and
training environment at Emory University and build on a robust ongoing and NIH-funded set of studies (1 cohort
and 2 active clinical trials) to experientially learn and teach these new skills. Specifically, I propose ancillary
studies to my active research that aim to: (d) validate endothelial-based proteins discovered in untargeted
proteomics in the CSF collected from individuals in my ongoing 3 studies and investigate if they are altered after
1 year of angiotensin receptor blocker treatment; and (e) to investigate the effect of ARBs on progenitor cells,
linked to AD, and perform a pilot study to assess if using scRNAseq on peripheral blood (with and without
pharmacological bone marrow mobilization) reveals differential functions of these cells. The success in
mentoring clinicians and scientists in POR to date and the robust and productive research activities ensures my
success. This K24 is a critical step in my midcareer to ultimately reach my leadership and independence goals.

Public health relevance
The goal of this K24 application is to build a research and training program focusing on investigating the role of the vascular system in Alzheimer’s disease. It includes both career and mentoring plans for new and junior investigators. It also supports 2 research projects that build on ongoing work and add new dimensions to mentoring and patient-oriented research.